PHYSIOLOGIC BASIS FOR INOTROPIC SUPPORT IN THE NEWBORN

To study the relationship between contractility, myocardial performance and circulating catecholamine levels in well term and preterm human infants, and in sick term and preterm infants; also to determine the dose response of blood pressure elevation, cardiac output, heart rate, and echo/Doppler indices of myocardial performance to administered dopamine in sick term and preterm infants.